Connecticut DCP RRT Maintenance

RRT Project Summary/Abstract
Maintenance for ConnecƟcut’s human and animal food Rapid Response Team (RRT). We are a mulƟ‐
agency RRT, for administraƟve purposes under the ConnecƟcut Department of Consumer ProtecƟon,
Division of Food, Standards and Product Safety. The Division also hosts the Manufactured Food
Regulatory Program Standards grant (the director of the program Frank Greene is also on the board of
the MFRP Alliance and is a past president).
We view the RRT as an interagency shared resource to work collaboraƟvely with our sister agencies
(Public Health, Agriculture, Lab, ﬁrst responders) and Federal partners on food incidents.

Public health relevance
Narrative The State of Connecticut has achieved project milestones for the Connecticut RRT for the period of last grant. The purpose of this grant is to maintain progress in CT’s Rapid Response Teams (RRTs) to facilitate long-term improvements and innovation to the national Integrated Food Safety Aystem by unifying and coordinating federal/state/local human and animal food (HAF) emergency response efforts including: 1) Strengthening the link among epidemiology, lab and environmental health/regulatory components. 2) Improving States' regulatory and surveillance HAF protection programs to include using Incident Command System (ICS)/National Incident Management System (NIMS) principles and a Unified Command structure to conduct integrated responses to all-hazards HAF emergencies, rapidly identifying and removing tainted food from commerce, and conducting root cause investigations to inform future prevention efforts; and 3) Addressing supporting components, such as training, data sharing, data analysis, communications, continuous process improvement, and development of best practices and other resources to support national response capacity/capability development.